Quality Of Life In Hiv Patients Receiving Structured Ver

Because of multi-drug regimens known as highly active antiretroviral therapy (HAART), HIV infection can now be considered a chronic, manageable disease for many people in the United States. However, these therapies come with complex medication regimens and numerous distressing side effects that may affect quality of life (QOL). The purpose of this study was to evaluate the QOL and symptom distress in individuals receiving structured intermittent (SIT) versus continuous HAART in the treatment of HIV disease. Adult HIV patients in the outpatient clinic completed questionnaires measuring QOL and symptom distress using Touch Screen computers at 7 timepoints over an 88 week period. Data collection for this study is completed. Analyses of the primary objectives have been conducted and disseminated at two national meetings and a publication.